Admin Core

Admin Core Project Summary
We propose to establish the Arizona Cancer and Evolution Center (ACE). Arizona State University will lead the
Arizona Cancer and Evolution Center effort. Drs. Maley and Shibata, co-principal investigators, will direct the
Center in collaboration with NCI program staff. ACE integrates a team of modelers, evolutionary biologists and
cancer biologists with a successful track-record of collaborations. The objective of the Arizona Cancer and
Evolution Center Administrative Core is to provide the necessary infrastructure for the overall organization and
effective management of the Center to achieve the objectives of the CSBC and the NCI, as well as realize the
scientific goals of the Center. The ACE Administrative Core will accomplish four Specific Aims during this
funding period: Aim 1 Create and maintain a knowledgeable, skilled, and interdisciplinary leadership team that
is connected to the research and the wider network; Aim 2 Design and implement a clear and effective
communication plan across the Center; Aim 3 Identify and foster pilot projects; Aim 4 Solicit, coordinate, and
respond to external advice for the scientific direction and opportunities for ACE. IMPACT: The Administrative
Core will enable the Arizona Cancer and Evolution Center to transform current understanding and
management of cancer by developing the theory, models, and measures of cancer that will be applicable and
clinically relevant across cancers and species.